University of Michigan Skin Biology and Diseases Resource-based Center

PROJECT SUMMARY - OVERALL
The overall goal of the University of Michigan Skin Biology and Diseases Resource-based Center (UM- SBDRC)
is to leverage our strengths in genomic editing, bioinformatics, and mouse modeling to enable a rapid transition
from discovery to function, address biological and disease context, and facilitate development of appropriate state-
of-the-art in silico approaches and in vivo mouse models of disease. Two Resource Cores have been established
within the UM-SBDRC: they will continue to enhance the efficiency and translational impact of cutaneous
research; provide access to unique resources and expertise; facilitate new discoveries; and provide training and
guidance regarding experimental design and analysis. In addition, the Resource Cores will continuously innovate
to maintain our research at the forefront of the field. The Functional Analytics Core will provide unique and
innovative, state-of-the-art services for CRISPR/Cas9 genome and epigenome editing services for the generation
of knockout, knock-in, and epigenome-modified keratinocytes, as well as functional characterization of these lines,
and access to state-of-the-art systems biology analyses, tools, training, and resources, including the Skin Gene
Query Tool, a searchable database with extensive disease- single-cell, spatial, and cytokine-specific gene
datasets. The Animal Modeling Core will continue to provide services for the design, development, validation,
and characterization of genetically-engineered mouse models (GEMMs) to aid in the functional validation of
results generated in the Functional Analytics Core. The Animal Modeling Core will provide resources and
guidance for GEMM phenotyping and in vivo manipulation, including transgene induction protocols, UV irradiation,
inflammation, fibrosis models, and for the establishment of cell cultures from GEMMs. The Administrative Core
will provide leadership, oversight, and structure for the UM-SBDRC by creating a streamlined platform for core
services for self-sustainability, management of material transfers of cell lines and other materials, and
enhancements to its enrichment program to encourage membership from diverse backgrounds. The Enrichment
Program includes a Mentoring Program, Pilot & Feasibility Program, Travel Awards, Visiting Speaker Series, and
an Annual Symposium, with strong institutional and departmental support for the Center. In summary, the UM-
SBDRC is in line with the NIAMS mission to provide critical research infrastructure, pooled facilities, services, and
resources to groups of investigators across disciplines to conduct research on skin biology and diseases. The
UM-SBDRC will enrich and enhance the effectiveness of ongoing basic and translational research, bring outside
investigators from diverse backgrounds into the field of cutaneous biology, broaden the scope of skin research,
and accelerate new discoveries to the benefit of our patients.

Public health relevance
PROJECT NARRATIVE With the shift in biomedical research towards big data and data-driven strategies, a major challenge is to robustly translate the vast amount of information generated into meaningful biological insights and clinically relevant information. The overall goal of the University of Michigan SBDRC is to leverage our strengths in genomic editing, bioinformatics, and mouse modeling to enable a rapid transition from discovery to function and to address biologic and disease context, as well as facilitating the development of appropriate state-of-the-art in silico and in vivo disease models. The key objective for UM-SBDRC is to accelerate ongoing skin research toward new discoveries and ultimately benefit a wide range of patients with cutaneous disorders.